Understanding the role of caregiver mental health in outcomes following childhood severe acute malnutrition

PROJECT SUMMARY/ABSTRACT
Caregivers of children with serious illness experience high burdens of depression and anxiety, which impacts
their own wellbeing and the wellbeing of those in their care. Severe acute malnutrition (SAM) is the most
serious form of acute malnutrition. Affecting millions of children each year primarily in sub-Saharan Africa and
South Asia, it typically involves cycles of acute illness, treatment, and often relapse. Children with SAM have 9
times the risk of mortality compared to their well-nourished peers, and families of children experiencing SAM
typically are experiencing extreme poverty and food insecurity. While postnatal depression has been shown to
increase the risk of infant undernutrition and affect breastfeeding practices, the impact of caregiver depression
on child outcomes among children with SAM is not well characterized. Here, we propose to add an ancillary
study to an ongoing randomized controlled trial evaluating treatment for SAM in Burkina Faso to longitudinally
measure caregiver depression and anxiety over the treatment course and up to 1 year following treatment of a
child’s SAM. By leveraging an existing trial collecting detailed data on child outcomes, we anticipate that this
study will provide comprehensive evidence of the burden of caregiver mental distress and the relationship
between caregiver depression and anxiety and recovery and relapse among children with SAM. This study will
provide critical data needed to inform development of interventions, such as community-health worker led
counseling programs or peer support groups, that may benefit caregivers of children with SAM and lead to
improved outcomes for children who are recovering from an episode of SAM.

Public health relevance
PROJECT NARRATIVE Postnatal depression has been shown to lead to reduced breastfeeding and increased risk of undernutrition among infants, and caregivers of children with severe acute malnutrition (SAM) have a substantially higher burden of depression compared to caregivers of children without acute malnutrition. Here, we propose an ancillary study to a randomized controlled trial enrolling children with SAM to evaluate caregiver depression and anxiety and how depression and anxiety influence outcomes among children from SAM and adherence to SAM treatment protocols. We anticipate that this work will lead to evidence to support the development and testing of an intervention to promote mental wellbeing among caregivers of children with SAM.